A Regionalized Approach to Achieving Conformance with the Voluntary National Retail Food Regulatory Program Standards

This application is a continuation of the work being done by five communities in Massachusetts to achieve compliance with the Standards. Our state is unusual in its delivery of public health in that each of the Commonwealth’s 351 cities and towns operate under Home Rule with its own Board of Health or Health Commissioner. It is a challenge to provide consistency in the work and quality of work performed by local health departments which range from one person operations to the Boston Health Commission. In order to take advantage of the efficiencies of working together, two cities and three towns have been working together the past five years on conformance with the Standards. We have created a Regional Food Safety Advisory Group that meets twice a year with a range of businesses including full service restaurants, school lunch programs, mobile food trucks, ethnic restaurants, and smaller “mom and pop” businesses. Having a larger pool of businesses involved allows us a broader range of participants. We have developed policies and procedures that are edited to meet the needs of the individual community. We work together to brainstorm solutions and enact consistent regulations. The business community has responded very positively to the work being done. Our relationships with industry has moved from suspicion and fear to one of collaboration. They appreciate the more professional and consistent inspections, not to mention the electronic inspection forms that they can easily read (handwriting on paper inspections was an issue, especially for those that did not read cursive or English was a second language). Standard 8 has allowed us to use national standards to show deficiencies in our staffing resulting in two of the communities allowed to increase their inspection capacity. A successful grant application will allow us to achieve: 1. Completion of most of the Standards 2. Assisting three other communities who have been enrolled in the Standards to achieve conformance with additional Standards.. We have been informally mentoring three other communities in their work to achieve the Standards. This grant will allow us to use some of the funds to assist them.

Public health relevance
Project Narrative This project is a continuation and expansion of work performed the past five years to maximize the number of communities and the number of Standards for each community to achieve conformance with the Voluntary national Retail Food Regulatory Program Standards.